Infrastructure Harmonization for DCP Enterprise System Knowledgebase (DESK) SupportPeriod of Performance 09/15/2014 - 09/14/2015

Infrastructure Support for the DCP Enterprise System Knowledgebase (DESK) Support